Influence of prostaglandin E2 on insect innate immune function

PROJECT SUMMARY
Prostaglandins are important bioactive signaling lipids with key roles in the regulation of inflammation and innate
immune function in both vertebrate and invertebrate systems. Derived from arachidonic acid, prostaglandins
mediate conserved physiological responses in response to pathogen-associated signals that stimulate the
activation, maturation, and migration of innate immune cells, conferring immune protection to infection. This
includes mosquitoes, where prostaglandins have previously described roles in anti-pathogen immunity, immune
cell function, and in mediating immune priming. Yet, despite the integral roles of prostaglandins on mosquito
immunity, studies of prostaglandins have been limited, leaving significant questions as to how prostaglandins
influence the mosquito innate immune system unanswered. Therefore, the overall objective of this application is
to examine the contributions of prostaglandin E2 (PGE2) on cellular and humoral immunity in the mosquito, An.
gambiae. Based on preliminary and previously published studies demonstrating that PGE signaling is an
important mediator of cellular immune function, immune priming, and in limiting pathogen survival, here we
outline experiments to address the cellular and transcriptional events following PGE2 activation using innovative
single-cell and phenomics-based methodologies (Aim 1); the mechanisms of PGE2-mediated immune priming
through recently developed genetic tools to promote tissue-specific silencing (Aim 2), and the potential of PGE2
dysregulation to influence pathogen infection outcomes and mosquito fitness by targeting enzymes involved in
PGE2 degradation (Aim 3). Therefore, we expect that the outcomes of our proposal will provide an important
fundamental insight into the mechanisms of PGE2 regulation, immune cell dynamics, and dysregulation of
PGE2-mediated immunity in an emerging model system. We believe these data provide an essential foundation
for future studies of mosquito PGE2 signaling and a valuable platform for comparative studies across
invertebrate and vertebrate systems. Importantly, the expected outcomes of our proposed experiments also have
tremendous potential for translation, where PGE2 dysregulation could serve as a novel target for mosquito
control to reduce the heavy burdens of mosquito-borne disease.

Public health relevance
PROJECT NARRATIVE With innate immunity serving as the primary line of defense to invading pathogens across biological systems, we outline experiments to examine the function of prostaglandin signaling in the mosquito host. With expected outcomes that will advance our mechanistic understanding of PGE2 signaling, the influence of PGE2 on immune cell function, and the impacts on PGE2-mediated immune dysregulation, the proposed studies will significantly advance our knowledge of PGE2 in insect immunity with potential translational implications to combat mosquito- borne disease. The resulting information and knowledge are relevant to the mission of NIH supporting basic research to understand biological processes that provide the foundation for advances in the diagnosis, treatment, and prevention of human disease.